T cell diversity during chronic inflammation

PROJECT SUMMARY
Thymus-derived lymphocytes (T cells) are an essential part of host defense and determine the specificity of the
immune response to antigens. The overall goal of this proposal is to examine T cells in a chronic inflammatory
condition. Inflammation can be driven by activation of various types of effector T cells or dysregulation of
regulatory T cells, however, whether these different subsets of T cells share the same TCR and recognize the
same antigen epitope is largely unknown. Furthermore, the link between gene expression and clonal expansion
at single cell level has not been established during chronic inflammation in the lung. We plan to perform single-
cell RNA sequencing of T cells from the airways of patients with advanced cystic fibrosis (CF) lung disease
compared to non-disease controls to fill this knowledge gap. We will use CF as a model to study chronic
inflammatory states in the lung. We hypothesize that T cells in the chronically inflamed CF airway have distinctly
different transcriptomic profiles compared to non-disease T cells, and using TCR analysis, we postulate
increased clonal expansion and Type 17 immunity bias will be observed in CF T cells. Our research aims include:
1) To investigate T cell phenotypes, gene regulatory pathways, and antigenicity within the CF airway and (2) To
validate top gene candidates of T cells within the CF airway identified using single-cell RNA sequencing.

Public health relevance
PROJECT NARRATIVE Thymus-derived lymphocytes (T cells) are an essential part of host defense and determine the specificity of the immune response to antigens. The overall goal of this proposal is to examine T cells in a chronic inflammatory condition. We will use single-cell RNA sequencing methodology to examine T cells from the airways of patients with chronic inflammation.